Intergenerational health impacts of interpersonal and community-based violence: From childbirth to childbearing

Project Summary
This proposal outlines a 3-year post-doctoral training fellowship, designed to prepare the trainee for a
career as an independent researcher at a major research university. The research and training plan are based
on the applicant's interest in studying social determinants of health and how violence and social stress are
structured and embodied in ways that can perpetuate health inequities across generations. Her career before
graduate school involved applied mixed method research and public policy advocacy for minority populations
experiencing disenfranchisement and human rights violations in Southeast Asia. During her graduate training
she gained advanced training in epidemiologic, demographic, and social research methods in order to study
structural causes of population health disparities. For her dissertation, she designed and completed her own
survey at the Thai-Myanmar border among refugees, migrants, and local residents in order to better evaluate
how maternal and child health is shaped by maternal life histories related to armed conflict, racism, military and
police surveillance, and other forms of violence. She recruited over 800 mother-child pairs, 520 of which
completed each survey component: in depth mother interviews, anthropometry, and hair sample collections.
The post-doctoral research and training that she proposes uses data she has already collected, along with
complementary datasets from Southeast Asia and the US, that allow her to examine more closely how violence
can influence maternal and child health, through social chains of risk and related biological mechanisms. She
will model maternal chains of risk triggered by violence and potentially leading to adverse birth outcomes, from
childbirth to childbearing, as they are indicated in life event histories collected among conflict- and
displacement-affected populations at the Thai-Myanmar border (Aim 1) and as they have been measured
prospectively in a US-representative cohort at the peak of family formation (Aim 2). She will focus in more
closely on maternal biological stress as a mediator of past violence and adverse birth outcomes by examining
how childhood and adolescent violence shape adult biological markers of stress and chronic inflammation
among mothers before and during pregnancy based on cohort data from the Philippines (Aim 3).
The proposed training plan involves the study of human biological and psychological models of stress and
health physiology, along with practical training in the bioassays and analysis of stress biomarker data, in order
to complete the proposed aims and prepare for an independent research career. Specific training goals
include: (1) Deepen understanding of stress physiology and biosocial pathways of embodiment; (2) Broaden
expertise with field-based longitudinal survey data collection and analysis; (3) Learn field-based stress data
and biospecimen collection and related lab techniques and analyses; and (4) Establish publication record,
prepare for faculty position, and write grants for future research.

Public health relevance
Narrative Violence affects at least 44% of women in the US, and more than one in three globally. The proposed research project is aimed at uncovering how burdens of violence experienced by women over the life course—from childbirth to childbearing—underlie long-term maternal stress and pregnancy health by getting “under the skin,” and potentially into the womb. Results from this project may improve our understanding of the biosocial pathways connecting violence and health over the life-course and intergenerationally, particularly among disproportionately affected populations, which may inform preventative policy and public health measures.